Core D: Community engagement core

CORE D Abstract/Summary
The Community Engagement Core (Core D) will provide a range of services to Center investigators to link with
our community partners and to train investigators and providers to implement a broad range of interventions for
treatment of mental illness, HIV, and their comorbidities. Specifically, Core D will: 1) provide linkage to
community partners where we have established relationships using expert services to support successful
implementation of HIV intervention projects, 2) provide expert consultation on the design of HIV Intervention
projects with consistent consideration of integration of both biomedical and behavioral science, and 3: provide
expert training that imparts knowledge and skills related to biomedical and behavioral scientific approaches to
HIV interventions. Many projects that Core D will support will be completed using established and standard
methods, and we have an explicit preference for using manualized treatments in “real world” settings and
comparative effectiveness and implementation science research methods. In general, Core D will utilize
personnel effort that is supported by the Core for pilot projects and preparation of funding proposals, with the
subsequent funded grants providing direct support of the resulting collaborative research effort. We have
established a bi-weekly HIV recruitment support group in collaboration with CFAR. The recruitment support
group provides assistance with recruitment efforts and has evolved into a joint effort within Penn including
PMHARC, CFAR, HVTN and Martin Delaney Collaboratory, as well as other local universities including Temple
and Drexel University. Core D is dedicated to building a portfolio over time that will combine comparative
effectiveness research, translation and implementation science, and community-based participatory research
(CBPR) methods. Building on the unique capacities available at Penn and in the Philadelphia area, the
Community Engagement Core will collaborate with other centers and institutes such as the Leonard Davis
Institute of Health Economics in the Wharton School and the Annenberg Public Policy Center to conduct cost-
effectiveness and other policy relevant analysis in order to plan for targeted dissemination to influence public
health policy regarding treatment of HIV among persons with psychiatric conditions. We will provide assistance
in grant proposal preparation; and potential users of the Core will be alerted of the resources. We also provide
a home for the Community Advisory Board (CAB) which will continue to assist with recruitment of participants
for research trials and dissemination of findings in the community.